Functionally distinct human CD4 T cell responses to novel evolutionarily selected M. tuberculosis antigens

Although CD4 T cells are essential for immunity to tuberculosis (TB), the features of CD4 T cells that provide
protective immunity are not well understood. This knowledge gap is due in part to limited knowledge of the M.
tuberculosis (Mtb) antigens that induce protective immune responses. In other pathogens, immune recognition
of some antigens provides protection, while recognition of other antigens does not. Likewise in other pathogens,
the antigenic targets of protective immunity undergo diversifying evolutionary selection to generate antigenic
variation and escape immune recognition. We hypothesized that these principles apply to Mtb, and in earlier
studies we made the unexpected discovery that the commonly-studied antigenic targets of human T cells
(epitopes) in Mtb are hyperconserved; they are the most conserved elements of the Mtb genome. We then
sought to find exceptions, and combined comparative genomics of phylogenetically diverse strains of Mtb with
experimental immunology. This led to our discovery of seven novel Mtb antigens (that we term Mtb Rare Variable
Antigens; RVA) that are recognized by human T cells and exhibit evidence of evolutionary diversifying selection.
Together, these results suggest that human T cell recognition of RVA is detrimental to Mtb and that recognition
of conserved 'classical' Mtb antigens is not detrimental to Mtb. We recently studied CD4 T cells from healthy
Quantiferon-TB positive (QFT+) recent close contacts of infectious cases of TB, and discovered that RVA induce
CD4 T cells characterized by dominant interleukin 17 responses and expression of the lineage-defining
transcription factor RORγt, in contrast to CD4 T cells that recognize classical Mtb antigens and exhibit interferon
gamma responses and expression of T-bet. These results indicate that human CD4 T cells that recognize RVA
are functionally distinct from those that recognize conserved antigens, and we hypothesize that T cells that
recognize RVA provide protection against active TB, as indicated by their evolutionary selection. In this project,
we will use innovative assays to intensively characterize CD4 T cells from QFT+ adults by comparing the features
of CD4 T cells that recognize RVA versus classical Mtb antigens. We will compare their functional responses,
longitudinal memory phenotypes, and extent of differentiation. We will also employ an innovative new platform
developed by our team, using DNA barcoded peptide epitopes and next generation sequencing to test the
hypothesis that associations between CD4 T cell antigen specificity and certain functional responses are
widespread in Mtb. To determine the significance of RVA in protective immunity to TB, we will compare CD4 T
cells that recognize RVA vs classical Mtb antigens in adults with active TB and those with 'controlled' (or latent)
TB. We will also test the hypothesis that defects in RVA-specific CD4 T cells are primary and do not reverse with
treatment of active TB. The long term objective of this project is to inform development of TB vaccines that
prevent progression to active TB disease, the form that causes human morbidity and mortality, and the form that
is responsible for TB transmission.

Public health relevance
Project Narrative While it is known that CD4 T cells protect against active tuberculosis, the M. tuberculosis antigens that are recognized by the CD4 T cells that provide protection remain to be identified. We identified a small set of M. tuberculosis antigens that are unusual for their evidence of evolutionary selection pressure and recognition by human and mouse CD4 T cells. In this proposed work, we will extend our discovery that human T cells that recognize these antigens exhibit distinct properties, and we will determine if CD4 T cells that recognize these antigens are associated with protection from active TB.